Core A: Administrative Core

ADMINISTRATIVE CORE SUMMARY
The Administrative Core will administer and lead the P01, including the other four Cores and the four Projects.
The Administrative Core is led by TIME-AD MPIs, with additional support from an Executive Committee
comprised of co-Investigators from across TIME-AD institutions. The Core will coordinate the complex project
to optimize use of common resources and results; ensure good communication; promote the scientific priorities
of rigorous prevention research, reproducible methodology, and health equity; and disseminate results to
relevant stakeholders. The Administrative Core will engage in the proactive monitoring of projects via a project
dashboard, annual planning meetings, monthly Executive Committee meetings, biweekly Administrative Core
leadership meetings, and other regular meetings within and across Projects. These activities will ensure
progress on the aims of the P01, including the development of the scientific teams, the implementation of
rigorous analyses, and translation from data to evidence via dissemination. As part of these responsibilities,
the Administrative Core will communicate with the NIA, including providing progress reports and less formal
updates on our accomplishments or any challenges that arise. The Core will set standards for authorship,
collaboration, decision-making, and resource sharing. Finally, the Administrative Core will be charged with
recruiting and supporting early career scholars who are currently affiliated with TIME-AD (e.g. the 11 co-
Investigators who are Early Career Investigators) or who will become affiliated over the study period. These
mentoring activities will be supported by a dedicated Project Manager as well as the many initiatives that
TIME-AD MPIs and co-Investigators are already involved with, including T32s, training-focused R13s and
R25s, and PhD programs. The Administrative Core Aims are to: 1) provide leadership for the P01 and direction
for its activities; 2) monitor timely progress, fidelity, quality, and effectiveness of operations of all Projects and
Cores and conduct all reporting activities; 3) maintain strong relationships through regular communication with
everyone involved in the project; 4) convene the External Advisory Board meetings; and 5) foster connections
with related Projects, including training and research initiatives, and chart the future projects and priorities for
the TIME-AD investigator community. Although the Equity and Dissemination Core will ensure this is infused
throughout the P01, the Administrative Core will also play a key role in overseeing equity emphases throughout
the Projects and Cores. In collaboration with Projects and Cores, we will have progress benchmarks, including
development of data sets, development of analytic code, preparation of publications, and dissemination of
results via peer-reviewed publications, scientific conferences, code-sharing platforms, and beyond, including
professional organizations, popular media, and other mechanisms to reach non-scientists.